Assessing the Sustainability of Compliance with Surgical Site Infection Prophylaxis After Discontinuation of Mandatory Active Reporting

Background: SSIs are common and preventable adverse surgical outcomes that account for substantial
morbidity and mortality. Pre-operative antimicrobial administration reduces SSI; post-operative antimicrobials do
not reduce SSI but do increase other post-operative adverse events. In 2005, the VA implemented the Surgical
Care Improvement Project (SCIP) to increase compliance with peri-operative quality metrics, including
appropriate antimicrobial use. SCIP included a set of publicly reported evidenced-based antimicrobial guideline
compliance metrics targeting high-risk surgeries. The metrics required resource-intense manual review as part
of the VA’s External Peer Review Program (EPRP). In 2015, SCIP achieved sustained compliance with
antimicrobial use metrics exceeding 95% and the program was retired due to the high costs of manual review
with minimal expected additional benefit. This IIR proposal is guided by the Dynamic Sustainability Framework
and examines whether the antimicrobial practice changes achieved by SCIP were sustained and how they
spread to surgeries and practice areas beyond the original scope of the program. This multiple PI submission by
Dr. Hillary Mull, PhD and Dr. Westyn Branch-Elliman, MD, MMSc builds and expands upon their prior VA-funded
collaborative work applying electronic algorithms to measure antimicrobial use and identify adverse outcomes.
Significance/Impact: Improving antimicrobial prescribing and surgical quality are major VA goals. In FY
2018, within the VA, there were 190,000 surgeries among SCIP-targeted specialties (cardiac, orthopedic,
general/colorectal, gynecology and vascular). Of these, 64% were outpatient, where the PIs found high rates
guideline discordant post-operative antimicrobial use, which contribute to substantial patient harms. Thus, the
potential impact of the research on direct clinical care is high. In addition, there are limited studies examining
what happens to practice change after discontinuation of active programs designed to support compliance with
evidence-based guidelines. The proposed study will close this gap in implementation science research.
Innovation: In line with the VA’s Learning Health System directive, this project will use the VA’s electronic
health record data to develop algorithms to identify pre-and post-operative antimicrobial use based on the PI’s
prior work. These electronic data mining algorithms capture structured and text note data and represent a
significant technological advancement over costly manual review. This study also answers important questions
about the sustainability of practice change after discontinuation of an active policy with input from frontline staff.
Specific Aims: 1) Measure sustainability of antimicrobial prophylaxis guideline compliance after SCIP
retirement and assess whether practice changes spread to SCIP-excluded procedures; 2) Assess facilitators
and barriers to implementation sustainability through staff interviews, and map results to implementation
strategies; 3) Develop an implementation playbook with assessment tools, training curricula and other elements
to support scale-up and spread of evidence-based antimicrobial practices in a future HSR&D Hybrid III trial.
Methodology: Aim I will adapt existing informatics algorithms to extract pre-and post-operative antimicrobial
use from clinical note texts and antimicrobial orders for each of the SCIP surgeries. Previously manually reviewed
2005-2015 EPRP data will be used as the gold-standard for adapting and refining the data mining tools. SCIP
sustainability will be measured by applying the validated antimicrobial compliance algorithms to 2005-2020 data
and performing interrupted time series analyses. SCIP spread within specialties will be assessed with regression
models. Aim II will use qualitative interviews with frontline staff to identify reasons for sustainability of evidence-
based practice using constructs in the Dynamic Sustainability Framework and will triangulate qualitative and
quantitative data to ascertain the long-term impacts of SCIP. Aim III will develop an implementation playbook
with input from our Operational Steering Committee comprised of national and local VA surgical stakeholders.
Next Steps/Implementation: Test implementation playbook in a Hybrid Type III study to improve practice.

Public health relevance
Surgical site infections are common and morbid; however, they are preventable with administration of evidence- based antimicrobial prophylaxis. In 2005, in the setting of high rates of non-compliance with antimicrobial prophylaxis guidelines, the VA implemented the Surgical Care Improvement Project (SCIP). SCIP included public reporting of evidenced-based antimicrobial guideline compliance metrics in high-risk surgeries and led to high rates of adoption of evidence-based practices (>95%). The program was retired in 2015, as the manual measurement and reporting process was costly with limited expected additional benefit. This IIR will use novel electronic algorithms to measure compliance with SCIP metrics over time, and stakeholder feedback to identify intervention strategies to sustain compliance. The aims are guided by the Dynamic Sustainability Framework and will address 1) the sustainability and spread of practice changes achieved by SCIP, 2) factors influencing sustainability, and 3) implementation strategies to test in a future Hybrid III trial to improve compliance.